Development of mRNA-platform vaccines

PROJECT SUMMARY
Pertussis is a respiratory disease caused by the obligate human pathogen Bordetella pertussis. Two generations
of pertussis vaccines have been developed and licensed: whole cell pertussis (DTP) and acellular pertussis
(DTaP/Tdap). Pertussis was thought to be a disease of the past but has recently re-emerged. The number of
cases of pertussis in 2012 was 48-fold over the lowest year on record (1976), which was also a 50-year high.
While the increase of pertussis has multiple potential reasons, epidemiological studies clearly suggest that the
duration of immunity of both DTaP and Tdap wanes quickly each year after a booster, and regresses to non-
protective levels in humans. Each dose of whole cell vaccine contains hundreds of antigens, of which numerous
are immunodominant. Whole cell vaccines also induce T helper 1 and 17 (Th1/Th17) cellular immune responses.
On the other hand, acellular vaccines focus Th2-mediated humoral responses exclusively to pertussis toxin,
filamentous hemagglutinin, pertactin, and fimbriae. We aim to develop a vaccine that would induce Th1
responses and include a greater number of antigens than acellular vaccines. mRNA vaccines provide a platform
that can be easily modified for the targeted antigen/pathogen and they induce Th1 responses. mRNA vaccines
encode the antigen, which once expressed, results in immunity mediated by Tfh responses. We used an mRNA
platform to screen antigens of B. pertussis and identified a protective multivalent formulation (mRNA-DTP10; 8
pertussis antigens with diphtheria and tetanus antigens) in a murine challenge model. In this project, we will
further extend our studies and investigate the correlates of protection of the mRNA-pertussis vaccine in the
murine model with longevity studies and examine DTaP prime / mRNA-boost effects (SA1). Next, we will utilize
the coughing rat model of pertussis with whole body plethysmography to compare mRNA, whole cell, and
acellular immunity for protection against cough (SA2). We will study the mRNA pertussis vaccine in
immunogenicity and challenge experiments using the baboon model of pertussis (SA3). Lastly, we will aim to
develop a suite of assays to phenotype antibodies produced by mRNA pertussis vaccines and bridge each of
the pertussis models, which will facilitate clinical development. Through these studies, we aim to characterize
the mRNA-pertussis immunity and develop a clearer understanding of how this vaccine platform can be used to
overcome “complex or difficult” pathogens that employ numerous virulence factors. We expect the data acquired
in each aim will result in a deeper understanding of pertussis immunity as well as illuminate the mRNA platform
for bacterial vaccines.

Public health relevance
PUBLIC HEALTH STATEMENT/PROJECT NARRATIVE The proposed research is relevant to public health because pertussis causes potentially deadly respiratory infections in children. Pertussis strains are circulating due to waning immunity of DTaP/Tdap vaccines as well as vaccine pressure. The re-emergence of pertussis indicates a critical need to develop new vaccine strategies, thus, the proposed research is relevant to NIH’s mission regarding enhancing health, lengthening life, and reducing illness.